Combinatorial Engineering of Multicellular Synthetic Immunotherapy Systems

Project Summary/Abstract:
Immune cells—T cells, natural killer (NK) cells, or macrophages—engineered to express synthetic receptors
have emerged as powerful anti-cancer treatments, but suffer from several shortcomings including short immune
cell persistence, immunosuppression by tumor associated macrophages, and failure to recognize evolving
tumors. Some of these problems might be overcome by co-engineering two receptors, chimeric antigen receptors
(CARs) and synthetic cytokine receptors (SCRs), to program immune cells with optimized anti-tumor properties.
A more ambitious strategy to improve cell therapies is to draw inspiration from the natural immune system, which
simultaneously deploys multiple immune cell types to mount an immune response, harnessing the unique
strengths of each cell type. This proposal outlines a research program in my lab to create new cell therapy
technologies that (1) co-optimize the signaling domains of CARs and SCRs to achieve enhanced anti-
tumor immune cell function, (2) co-engineer T cells, NK cells, and macrophages to synergize as a
synthetic immune system against cancer, and (3) train machine learning models to predict and
understand how synthetic receptors encode the functions of these engineered immune cells. We have
developed a platform to rapidly build hundreds to thousands of synthetic signaling proteins and screen them in
primary human immune cells in pooled or arrayed contexts. In previous work and pilot studies, we have shown
that this platform enables generation of receptors with diverse effects on immune cell phenotypes such as tumor
killing and immune cell state, and that library screening data can be used to train machine learning models for
rational cell therapy design. Our lab will adapt this platform to optimize pairs of synthetic receptors that
enhance immune cell survival, resistance to immune suppression, and tumor killing. We will use synthetic
receptors that encode diverse phenotypes to create the first synthetic immune systems in which T cells, NK
cells, and macrophages synergize to effectively target cancers. Screening and analysis of synthetic receptor
libraries will reveal how crosstalk between two engineered signaling domains encodes cell functions, and how
engineered immune cells interact in the context of a synthetic anti-cancer immune system. Neural networks and
dynamical models trained on the data will uncover design rules that aid in development of next-generation
cell therapies. This work will expand the scales on which we engineer immune cells, enabling us to co-engineer
multiple receptors to work together within a cell, and to engineer multiple cell types to work together as a cell
therapy.

Public health relevance
Project Narrative: We have developed a platform for rapidly constructing and screening combinatorial libraries of hundreds to thousands of synthetic receptors that reprogram T cell function, enabling the first machine learning-guided design of an improved cell therapy prototype (Daniels et al., 2022). We will adapt this platform to co-optimize synthetic receptor pairs that enhance immune cell (T cells, natural killer cells, and macrophages) anti-tumor activity, and to create synthetic immune systems in which T cells, natural killer cells, and macrophages synergize against cancer. Library screen data and machine learning models trained on that data will improve our understanding of receptor-receptor interactions and cell-cell interactions, yielding design rules for next-generation cell therapies.